The role of microglia in TRPV4 mediated neurodegeneration

Project Summary/Abstract
Microglia play diverse roles in neurodegenerative disorders such as Alzheimer’s disease, multiple sclerosis, and
the motor neuron diseases amyotrophic lateral sclerosis (ALS) and spinal muscular atrophy (SMA). Recent
studies have revealed subtypes of microglia with varying molecular signatures and functions, indicating
differential responses to stimuli and environmental cues. This heterogeneity suggests that microglia have distinct
downstream effects on disease progression. Importantly, breakdown of blood-CNS barriers (BCNSBs; e.g.,
blood-brain and blood-spinal cord barrier) and leakage of serum proteins into the CNS can activate microglia.
However, the identity of these microglial subpopulations and their disease contributions are incompletely
understood due to the multifactorial etiologies of many neurodegenerative disorders, where BCNSB breakdown
plays only a contributing role. My research aims to characterize specific subpopulations of microglia and
determine their contributions to transient receptor potential vanilloid 4 (TRPV4)-mediated motor neuron
degeneration. Gain-of-function mutations of TRPV4 causes forms of distal SMA. Recently our laboratory has
demonstrated that mutant TRPV4 mice develop severe muscle weakness, motor neuron loss, and lethality due
to spontaneous BCNSB opening in the ventral horn of the spinal cord. These deficits can be prevented by genetic
ablation of TRPV4 from vascular endothelial cells or pharmacological inhibition of TRPV4. This model provides
a unique opportunity to understand the microglial subpopulations activated by BCNSB breakdown in the spinal
cord and their role in motor neuron degeneration. In preliminary data, I have observed two distinct, activated
microglial populations: one at early disease stages around leaking vessels and another at late stages clustering
around degenerating motor neurons. In Specific Aim 1, I will further characterize the spatial patterns of microglia
activation in relation to vascular leak and motor neuron degeneration in mutant TRPV4 mice at various time
points and following treatment with a TRPV4 antagonist. In Specific Aim 2, I will define the evolution of molecular
subtypes of microglia post-BCNSB breakdown using single-cell RNA sequencing. In Specific Aim 3, I will
investigate the functional contributions of microglia to BCNSB breakdown and motor neuron dysfunction. By
dissecting the interplay between microglial activation, BCNSB dysfunction, and motor neuron degeneration, I
aim to unravel mechanisms driving neuroinflammatory degenerative processes in the spinal cord, which might
ultimately offer novel therapeutic approaches. This work will not only shed light on the pathogenesis of TRPV4-
mediated motor neuron disease, but will offer insights into other neurodegenerative disorders in which BCNSB
breakdown triggers neuroinflammation.

Public health relevance
Project Narrative I aim to characterize the identity and roles of microglia in TRPV4 (transient receptor potential vanilloid 4)- mediated motor neuron degeneration. Neurodegeneration in mutant TRPV4 mice is caused by blood-CNS barrier (BCNSB) breakdown and this mouse model provides an opportunity to characterize the specific microglial subpopulations activated by vascular leak and their roles in disease. This work will advance our understanding of neuroinflammatory processes triggered by BCNSB breakdown and potentially identify novel therapeutic strategies.